Interplay between neuroprotective pathways, HIV, and astrocytes

[unreadable] DESCRIPTION (provided by applicant): HIV causes neurologic disorders (NeuroAIDS) ranging from minor cognitive and motor disorders to HIV- associated dementia (HAD). A better understanding of the underlying mechanisms of NeuroAIDS is needed because it would suggest therapeutic approaches for NeuroAIDS. Towards this goal, our strategy is to define the interplay between endogenous neuroprotective mechanisms and HIV in brain cells. Wnt/2-catenin activity is a pro-survival signal in neurons and astrocytes. Wnt/2-catenin regulates ~500 genes involved in diverse cell functions such as cell proliferation and survival throughout the body, including the CNS. Mounting evidence links decreased levels of 2-catenin and neurodegeneration. Yet, the role of Wnt/2-catenin activity in NeuroAIDS is unclear. We reported an inverse relationship between Wnt/2-catenin activity and HIV replication. Specifically, we demonstrated that active Wnt/2-catenin inhibits whereas inactive Wnt/2-catenin induces HIV replication. Further, IFN3, a proinflammatory cytokine associated with HAD severity, and Tat, an HIV-encoded regulatory protein, both diminished Wnt/2-catenin signaling in astrocytes. We propose that (i) Wnt/2-catenin signaling (Wnt) is a key regulator of HIV replication and homeostasis in the brain, and (ii) Wnt down-regulation (mediated by Tat or IFN3) promotes astrocyte and neuronal apoptosis, which contributes to the pathogenesis of HIV disease in the CNS. In Aim 1, using astrocytes (which have high endogenous Wnt/2-catenin expression) we will define the mechanism by which Wnt/2-catenin regulates HIV replication. In Aim 2, using astrocytes, microglia, and monocyte-derived macrophages, we will determine the role of host (IFN3) and viral (Tat) factors in modulating Wnt/2-catenin signaling and HIV replication. In Aim 3, using primary human fetal mixed glial/neuronal brain cell cultures, we will determine the consequences of modulation of brain Wnt activity on the survival of astrocytes and neurons. Collectively, these studies will lead to a better understanding of the role of brain Wnt/2-catenin activity on HIV replication and glial/neuronal survival. These studies could also expedite the development of activators of 2-catenin signaling that can penetrate the CNS, suppress HIV replication, and enhance survival of astrocytes and neurons. PUBLIC HEALTH RELEVANCE: Despite anti-HIV drug therapy, approximately 50% of HIV-infected individuals develop cognitive and motor disorder. This may be due to the poor permeability of current anti-HIV drugs into the brain. Because neurons are not directly infected by HIV, their death/dysregulation is thought to occur through indirect events. Our application will examine the interplay between a pathway that is defined as neuroprotective (Wnt/2-catenin), HIV replication in brain cells, and role of astrocytes in mediating HIV-associated neuropathogenesis. We have established that the Wnt/2-catenin pathway inhibits HIV replication. When this pathway is on, HIV level is low and when it is off, HIV level is high. We demonstrated this relationship in astrocytes, which express high level of Wnt/2-catenin. When astrocytes were first treated with IFN3 then infected, HIV levels were higher. This then suggests that signals that turn off this pathway, such as IFN3, will allow for burst of low-level of HIV. This will then lead to increased Tat level (a viral protein that is linked to apoptosis of astrocytes and neurons). Tat, we demonstrated, in turn turns off the Wnt/2-catenin pathway, leading to higher level of HIV replication in HIV target cells. The consequence of these events is diminished Wnt/2-catenin activity in the brain, which will lead to increased susceptibility of astrocytes and neurons to cell death. This model places the Wnt/2-catenin pathway at the interface of HIV-mediated neuropathogenesis through both direct (active HIV replication) and indirect (enhanced cell death) events. Clarifying this interplay could lead to novel drug strategies to combat HIV infection in the brain. [unreadable] [unreadable] [unreadable]

Public health relevance
Despite anti-HIV drug therapy, approximately 50% of HIV-infected individuals develop cognitive and motor disorder. This may be due to the poor permeability of current anti-HIV drugs into the brain. Because neurons are not directly infected by HIV, their death/dysregulation is thought to occur through indirect events. Our application will examine the interplay between a pathway that is defined as neuroprotective (Wnt/β-catenin), HIV replication in brain cells, and role of astrocytes in mediating HIV-associated neuropathogenesis. We have established that the Wnt/β-catenin pathway inhibits HIV replication. When this pathway is on, HIV level is low and when it is off, HIV level is high. We demonstrated this relationship in astrocytes, which express high level of Wnt/β-catenin. When astrocytes were first treated with IFNγ then infected, HIV levels were higher. This then suggests that signals that turn off this pathway, such as IFNγ, will allow for burst of low-level of HIV. This will then lead to increased Tat level (a viral protein that is linked to apoptosis of astrocytes and neurons). Tat, we demonstrated, in turn turns off the Wnt/β-catenin pathway, leading to higher level of HIV replication in HIV target cells . The consequence of these events is diminished Wnt/β-catenin activity in the brain, which will lead to increased susceptibility of astrocytes and neurons to cell death. This model places the Wnt/β-catenin pathway at the interface of HIV-mediated neuropathogenesis through both direct (active HIV replication) and indirect (enhanced cell death) events. Clarifying this interplay could lead to novel drug strategies to combat HIV infection in the brain.